Turicibacter modifies intestinal infection severity by modulating intestinal metabolites

SUMMARY
Diarrheal diseases are a leading cause of child mortality worldwide, causing approximately 800,000 deaths per
year in children under five years of age, and prevalent morbidity in adults. For bacterial diarrheal infections,
antibiotics are often the primary treatment; however, their heavy use disrupts beneficial microbial communities,
which, in turn, exacerbates disease outcomes. A crucial approach to treat or prevent these infections involves
restoring or modulating the gut microbiota with specific commensals that offer targeted protection against
pathogens. Although fecal transplantation is one potential method, it is limited by the risk of transferring harmful
pathogens to the recipients. Interestingly, commensal bacteria can influence the composition of intestinal
metabolites, which may play a crucial role in either curbing or promoting pathogenicity. Therefore, manipulating
these metabolites presents a promising therapeutic avenue to prevent severe diseases caused by intestinal
pathogens. Research focused on identifying protective commensals and key metabolites is essential for
developing effective prevention strategies against bacterial diarrheal diseases. In this application, we present
compelling preliminary findings suggesting that the commensal Turicibacter sanguinis may protect against
severe disease caused by the intestinal pathogen Citrobacter rodentium, an established model of attaching and
effacing (A/E) bacterial infections in mice. While little is known about T. sanguinis, recent studies have shown
that higher levels of this commensal correlate with healthier outcomes in children with diarrhea or acute
gastroenteritis, hinting at a potential protective association against diarrheal diseases in humans. Consistent with
these observations, our data show that severe disease from C. rodentium is linked to the absence of T. sanguinis
and elevated intestinal levels of two specific metabolites: adenine and dioscoretine. Based on these findings, we
hypothesize that adenine and dioscoretine create an intestinal environment conducive to severe C. rodentium
infection, whereas T. sanguinis confers resistance by reducing these metabolites' abundance.

Public health relevance
Narrative The intestinal microbiota and metabolites are key to maintain host's homeostasis, including protection against pathogens. In this application we present evidence supporting the hypothesis that the commensal Turicibacter sanguinis and two associated metabolites (adenine and dioscoretine) have an important role during severe intestinal infections.